Measuring and manipulating stress-responsive neuronal activity to improve post-stroke outcomes

Stroke is a severe ischemic neurovascular injury, with high rates of incidence in the developed world, high
mortality, and long-term disability for survivors. It is critical for the development of improved interventions that
novel therapies take into account post-ischemic stroke (IS) temporality to target appropriate time windows
for intervention. Hypothalamic-pituitary-adrenal (HPA) axis activation, which effectuates the neuroendocrine
stress response, is elevated in the hyperacute phase post-IS, increasing corticotropin releasing hormone
(CRH) and corticosteroid (CORT) signaling. Elevated stress and HPA activity pre-IS is associated with worse
outcomes, and hypercortisolism in the subacute and chronic phases is both typical and deleterious. The
hippocampus provides crucial negative feedback regulation of the HPA axis, and secondary post-IS damage
to the hippocampus is common. Secondary damage to the hippocampus post-IS may depend on corticoiddependent
signaling; this could set up a feed-forward loop whereby post-stroke potentiation of stress
signaling propagates itself, promoting further excitotoxicity and neurodegeneration.
A growing body of evidence suggests that targeting CRH signaling could reduce post-IS morbidity and
mortality; this includes advanced anti-CRH antibody treatment and CRF1R antagonism. CNS control of HPA
axis activation is likely a major contributor to CRH and corticoid elevation post-IS. The ventral hippocampus
regulates CRH production and HPA activation through excitatory projections to the bed nucleus of the stria
terminalis (BNST), which in turn sends inhibitory projections to CRH+ neurons in the paraventricular nucleus
(PVN) of the hypothalamus. This circuit represents a viable target for temporally-modulated interventions
after stroke. In this proposal we will investigate how BNST and PVN neuronal activity changes acutely poststroke,
and how modulating the activity of key neuronal populations in these nuclei will be effective in
improving functional outcomes and reducing neuronal damage in the hippocampus and throughout the brain
after ischemia.